Modifying fragility fracture healing using a gradient-based mechanotransduction fixation approach

PROJECT SUMMARY
Candidate: Dr. Hast received his bachelor's degree in mechanical engineering with a focus on thermodynamics
and a Ph.D. in mechanical engineering with a focus on computational biomechanics. His long-term goal is to
become an independent researcher focused on improving patient outcomes following fragility fractures. This
proposal uses an interdisciplinary research framework using a small animal model to identify mechanisms that
govern fracture healing in healthy and diseased bone. The objective of this proposal is to have Dr. Hast acquire
the training necessary in small animal models, cellular assays, and molecular laboratory techniques to fully
define the mechanisms that govern callus formation and bone remodeling in the milieu of osteoporosis. This will
equip him with the tools necessary to become a thought leader in the field of fragility fracture repair.
Mentoring Committee and Training Plan: Dr. Mauck will serve as primary mentor and provide structured
mentoring in tissue engineering, laboratory techniques, and provide career development training. Drs. Boerckel
and Qin will serve as co-mentors and provide hands-on training in small animal surgeries, histology,
immunohistochemistry, and molecular profiling. Dr. Hast will also have advisory committees (technical: Drs. Liu,
Ahn, Mehta, Manogharan; career: Drs. Soslowsky, Arbogast, Elliott) to guide his development. Dr. Hast will
participate regularly in faculty meetings, seminars, workshops, and coursework to make him a complete and
independent researcher. He will present his research at national conferences and in peer-reviewed journals.
Environment: The University of Pennsylvania is home to the McKay Orthopaedic Research Laboratory and Penn
Center for Musculoskeletal Disorders (PCMD), a 22,00 ft2 research space that is well-equipped for the proposed
training and research plan. The PCMD and hosts several NIH supported core services focused on
musculoskeletal research, which include histology, biomechanics, and imaging. Both the PCMD and Penn host
weekly/monthly seminars in cellular and molecular biology, medical imaging, bioengineering, and professional
development.
Research: This proposed work will challenge the current clinical paradigms that use metal implants to heal
fractures. The central hypothesis is that properly timed gradual (gradient-based) increases in loading will lead to
improved repair of simulated fractures. To test this novel hypothesis, a rat model will be used in 2 aims. Aim 1
will establish the effects of gradual introduction of mechanotransduction on fracture repair in healthy bone. Aim
2 will determine what changes in mechanotransduction are required to improve fracture repair in compromised
bone. Testing these aims will generate critical preliminary data for a follow-up R01 that includes a larger animal
model, along with pharmacological interventions that may accelerate and improve repair.
Institutional Commitment to Candidate: Dr. Hast is an Assistant Research Professor and has been provided
start-up funds, laboratory space, and research personnel needed to perform the proposed work.

Public health relevance
PROJECT NARRATIVE Fragility fractures are common injuries that have direct implications on patient function and mortality. This proposal uses bioresorbable implants to investigate the effects of gradual introduction of micromotion within the fracture callus in the presence of healthy and compromised bone. These findings will provide new insights into the role of mechanotransduction and clinical standards of care, while establishing a research framework for developing and optimizing implant designs that will improve patient outcomes.